O-GLCNAC HOMEOSTASIS REGULATES MITOCHONDRIAL FUNCTION IN ALZHEIMER'S DISEASE

Project Summary:
Currently, 6.9 million Americans are suffering from Alzheimer's disease (AD), which is the only major disease
lacking good prevention methods, treatments, or a cure. Our objective is to determine the mechanisms as to
how nutrient sensing as interpreted by O-GlcNAcylation, a dynamic single sugar modification, influences
mitochondrial function in Alzheimer's disease (AD). O-GlcNAc is categorized by the addition of a single O-
linked β-N-acetyl-D-glucosamine moiety to serine/threonine amino acids of nuclear and cytoplasmic proteins.
This modification is responsive to extracellular signals such hormones, nutrients, and environmental cues and
is involved in regulating numerous cellular functions such as the cell cycle, stress response, transcription, and
translation. The enzymes responsible for processing the modification are O-GlcNAc transferase (OGT), which
adds the modification, and O-GlcNAcase (OGA), which removes the modification. Importantly, changes in O-
GlcNAcylation alter mitochondrial function. Cells actively maintain homeostatic levels in O-GlcNAc, and cells
will alter the expression of OGT and OGA to modulate O-GlcNAcylation due to changes in the environment.
We hypothesize that the loss of O-GlcNAc homeostasis causes mitochondrial dysfunction promoting the onset
and progression of AD. Supporting this hypothesis, we recently demonstrated that O-GlcNAc regulates
mitochondrial respiration, mitophagy, and mitochondrial retrograde signaling; thus, we generated two specific
aims to test this hypothesis, and we have developed several O-GlcNAc related tools to accomplish our goals.
In aim 1, we will elucidate O-GlcNAc mechanistic control of mitochondrial function by identifying the OGT and
OGA mitochondrial interactome in control and AD mitochondria and test how these interactions impact
mitochondrial function; identify electron transport proteins that prefer to interact with O-GlcNAcylated proteins
and how these interactions affect energetics; elucidate the function of O-GlcNAc on PINK1 (PTEN Induced
Kinase 1), which is key regulator of mitophagy, and lastly explore sex-specific effects of OGA inhibition (a
potential AD therapeutic) on mitochondrial function. These data will provide novel mechanistic information on
how O-GlcNAc and the functions of OGT and OGA contribute to mitochondrial function and AD development.
In our second aim, we will ascertain how altered O-GlcNAc nutrient sensing affects mitochondrial retrograde
signaling to the nucleus. We identified that the function of retrograde signaling transcription factors ATF4
(Activating Transcription Factor 4) and NRF2 (Nuclear Factor erythroid 2) are modulated by O-GlcNAc. We
will employ a novel CRISPR based targeting of OGT and OGA to ATF4 and NRF2 target gene promoters to
determine how O-GlcNAcylation organizes cis-regulatory elements at these promoters. Next, we will identify
how O-GlcNAc on NRF2 affects NRF2 function. Together, these data will demonstrate the role of O-GlcNAc
homeostasis in regulating nuclear mitochondrial gene expression through mitochondria retrograde signaling.
Collectively, these results will provide new mechanistic pathways in our understanding of AD.

Public health relevance
Project Narrative: O-GlcNAcylation is the attachment of a single O-linked β-N-acetyl-D-glucosamine moiety to serine/threonine residues of nuclear, mitochondrial, and cytoplasmic proteins; as such, this modification regulates numerous cellular process such transcription, translation, cell cycle, and signaling. Importantly, O-GlcNAc is a critical regulator of mitochondrial function and disruption in the normal homeostatic levels of O-GlcNAc impairs respiration. This proposal will develop a new understanding of how O-GlcNAc regulates mitochondrial respiration and anti-oxidant response in the context of Alzheimer’s disease.